Clinical Protocol and Data Management

CLINICAL PROTOCOL AND DATA MANAGEMENT
PROJECT SUMMARY/ABSTRACT
The purpose of the Office of Human Research Services (OHRS) is to enable and enhance clinical and
translational research across the consortium by providing Rutgers Cancer Institute of New Jersey (CINJ)
members with centralized resources, information and expertise in clinical research. OHRS has the responsibility
of working with clinical investigators to manage the business, clinical and regulatory functions of all phases of
pediatric and adult interventional/non-interventional trials at CINJ. The current organizational structure is
comprised of approximately 70 FTEs and six functional offices including clinical operations, quality assurance,
and regulatory affairs.
The activity and use of OHRS parallels the growth of the center and has increased as the number of CINJ
investigators and oncology faculty increased. In the most recent grant period (2011-2017) the OHRS managed
enrollment of 26,432 patients, compared to the seven-year interval corresponding to the previous grant period
(2004-2010) in which 11,454 patients were enrolled. Currently, there are 154 active enrolling trials (92
therapeutic) supported by the OHRS. Given an overall Center initiative to enhance translation of center science,
OHRS has increased its support for investigator-initiated and multi-center trials and continues to be used
extensively by CINJ members.